MITF from control of pigmentation to melanoma risk

Abstract
Human skin phototypes are routinely described in a gradient of 1 (redhaired) to 6 (dark constitutive pigment)
which correlates with UV sensitivity and risk of melanoma. Parallel to this gradient is the increase of nevi (moles)
from darker to lighter phototypes, a gradient which abruptly drops at phototype 1 (redhaired) where visible nevi
are unexpectedly rare. We hypothesized, and verified in murine models, that BRAFV600E- induced nevi in
redhaired mice are “invisible” but actually significantly more abundant compared to genetically matched black
mice. They are clinically inapparent due to lack of dark eumelanin, but are easily identified via fluorescence
tagging, and associated with profoundly elevated spontaneous melanoma transformation and UVA-induced
melanoma risk in redhaired mice. This melanoma risk was traced to red pigment because “albino-redhaired”
mice lack all pigment and are protected from either spontaneous (previously published), UVA-induced, or
peroxide-induced melanoma. Spontaneous and UVA-induced “invisible” nevi and melanoma-genesis are
proposed for study in Aims 1 and 2 for NRASQ61R pigment models, the 2nd most common human nevus and
melanoma oncogene, to complement our extensive unpublished data for BRAFV600E. Several small molecule
approaches will be tested to potentially mitigate pheomelanin-induced melanoma risk including induction of dark
eumelanin synthesis. One such example was already seen to ”reveal” visible lesions in the “invisible” nevus-
bearing redhaired mice. In addition, the fluorescent nevi, engineered into isogenic pigment backgrounds, will be
flow-sorted from skin and transcriptomically scrutinized to mechanistically dissect the pathways and genes
(including redox) that mediate the elevated melanoma risk among fair skinned individuals. Only a minority of
melanomas arise from pre-existing nevi, so we use our models to examine both nevi and overall melanoma risk.
We also discovered that the Parkinson’s Disease therapy L-Dopa significantly elevates pheomelanin synthesis
in redheads. Separate from being a dopamine precursor, L-Dopa is coincidentally a chemical intermediate in
melanin biosynthesis. Parkinson’s Disease and melanoma have long been associated with one another, but
lacking a mechanistic explanation. We observed that low dose L-Dopa significantly elevates melanoma risk in
BRAFV600E redhaired, but not in albino-red mouse models (which cannot make pheomelanin or eumelanin). Aim
3 will test L-Dopa’s melanoma causality in NRASQ61R redhaired models and whether topical skin darkening may
modify the enhanced melanoma risk already observed for BRAFV600E. Finally, Aim 4 will examine the hypothesis
that MITF regulates expression of an anti-oxidant pathway which includes enzymes controlling regeneration of
reduced NADPH and glutathione—key factors buffering melanocyte oxidative stress. One such enzyme, the
mitochondrial enzyme NNT, was recently shown to modulate melanocyte redox and melanosome differentiation.
We will test evidence that NNT is a transcriptional target of MITF and functionally scrutinize a newly identified
sequence variant in NNT, nominated by NCI collaborators as a candidate familial melanoma gene in humans.

Public health relevance
Narrative Our study examines the role of melanin pigments in melanoma susceptibility, based upon several recent discoveries: that the redhair background is associated with numerous “invisible” moles, that these moles have significantly elevated risk of melanoma transformation (spontaneously or after UV exposure), and that the Parkinson’s Disease drug L-Dopa further amplifies this melanoma risk by unexpectedly stimulating red pigment synthesis. These studies will employ a series of genetically engineered mouse models to dissect pathways of elevated melanoma risk and several strategies aimed at diminishing the melanoma risk, based on elucidation of the underlying mechanisms.